Illinois Occupational Surveillance Program

Project Summary
The Illinois occupational surveillance program, now in its 11th year of funding, is seeking program renewal in
order to continue to pursue population and case based occupational surveillance activities with the goal of
proactively identify emerging hazards and promoting policies to protect workers. As the bona fide agent of the
Illinois Department of Public Health, our research team at the University of Illinois Chicago, School of Public
Health has taken on the role of building occupational health surveillance capacity in Illinois.
We are applying for an expanded program comprising of a fundamental program and three expanded
projects. We plan to continue to lead the effort in the state of Illinois to enhance occupational safety and
health surveillance with the following programs:
-Fundamental Illinois Occupational Surveillance Program: Conduct active surveillance of occupational
injuries and illnesses in the State of Illinois utilizing recognized and new data systems with a particular focus on
high risk industries, as well as underserved and precarious workers. We will expand health informatics
capacity, organize statewide communications, and continue to build partnerships with stakeholders.
- Expanded Project #1- Linking Occupational Surveillance Data, Work Practices and OSHA
Enforcement Activities in Illinois: We aim to develop a “system of systems” through coordination with OSHA
and other public health stakeholders in Illinois. The proposed program will (1) develop a real-time surveillance
program to inform OSHA’s unprogrammed inspections, (2) analyze occupational injury and illness data
captured in data systems not available to OSHA in order to identify high risk industries, employers with
recurring severe injuries, and characterize emerging hazards to inform OSHA’s programmed inspections, (3)
assess the reliability of employer reporting of severe injuries, and (4) strategically coordinate efforts between
OSHA and other stakeholders.
- Expanded Project #2 - Work-related Injuries in Chiropractors: Surveillance and Training: We will
conduct occupational surveillance of ergonomic hazards and musculoskeletal health risks among
chiropractors. We will also develop continuing education material, deploy a CE course through a partnership
with the national association, and survey chiropractors about workplace hazards, knowledge regarding injury
prevention and barriers to mitigating these ergonomic hazards.
-Expanded Project #3 - Pesticide Related Illness Surveillance Program: Develop occupational surveillance
system to monitor pesticide related illnesses and use these data to develop outreach and training among high
risk workers. We will build a collaborative network of stakeholders to assess and engage workers with the goal
of reducing pesticide related illnesses in Illinois.

Public health relevance
Project Narrative Through this expanded project, we aim to improve occupational surveillance and public health practice in Illinois by strategically linking surveillance data, work practices and enforcement activities through a network of occupational health stakeholders. These activities are integral to understanding, highlighting, and proactively preventing injuries and illnesses caused by chronic and emerging hazards at work. While the goal of our surveillance program is to improve health and safety across the entire workforce, we continue to focus on issues affecting the most vulnerable workers in Illinois and underserved populations.